The District of Columbia Clinical Trials Unit (DC CTU)

Project Summary
The District of Columbia Clinical Trials Unit (DC CTU) will conduct clinical trials for persons with and at risk for
HIV in DC, where 1.8% of the overall population and 2.7% of the African-American population are living with
HIV. The DC CTU will unite two existing, high-performing DAIDS/NIAID Clinical Research Sites (CRS), the
Whitman-Walker Health CRS and the George Washington University CRS, in a new CTU, participating in the
HIV/AIDS Adult Therapeutics and HIV Prevention Clinical Trials Networks. Our innovative and geographically-
focused DC CTU will ensure exemplary clinical trials management, recruitment, and retention of a diverse
sample of participants, with a community engagement strategy built on existing partnerships and Good
Participatory Practices. The DC CTU will achieve four specific aims: 1) Provide scientific leadership and
administrative infrastructure to allow high-quality conduct of therapeutic and prevention studies at two
established CRSs; 2) Implement best practices to ensure continued high recruitment and retention rates;
participant safety; and laboratory, pharmacy, data, and regulatory excellence; 3) Actively engage with the local
community to ensure optimal enrollment of diverse participants from within and beyond clinic settings using
Good Participatory Practices; and 4) Capitalize on the resources available from the DC CFAR and DC Cohort
to engage senior investigators, mentor investigators in clinical trials conduct, and access a broad array of
services to address NIH and network scientific and programmatic priorities. The DC CTU will engage
participants who can benefit from innovative clinical trials while we contribute to high-quality participatory
research that will eventually end the HIV epidemic.

Public health relevance
Project Narrative The newly formed District of Columbia Clinical Trials Unit (DC CTU) is a regionally-focused CTU designed to address the HIV epidemic in the nation’s capital, one of the most severely affected areas in the United States. The DC CTU unites two experienced, high-impact clinical research sites and will conduct HIV prevention, treatment, and cure trials. In concert with the community, the DC CTU will contribute to trials that will eventually help end the HIV epidemic.